Administrative Core

The Administrative Core is responsible for the administrative planning, oversight, implementation, and management of the Center. The primary role of the Administrative Core is to achieve integration across projects and cores, foster synergy, manage risks, support researchers and students in effectively conducting research and translating that research to the public. The specific aims of the Administrative Core include: (1) facilitating the work of Center investigators; (2) organizing regular meetings and information sharing opportunities enhancing collaboration and efficient problem solving across the Center; (3) engaging advisory boards to assist with review and counsel for the Center's activities; (4) monitoring and evaluating the progress being made; and (5) promote multidisciplinary investigation. The Center has been productive for the last 15 years and we view this cycle as the opportunity for translation of the cumulative foundational work already done with the addition of some related new ideas. In this cycle we will build upon the basic and applied research of the past with a special emphasis on planful dissemination and implementation (Brownson, et al 2018). During this cycle, we will take a more focused and targeted approach to ensure that our research reaches and positively impacts children with disabilities, as well as the families and educators who support them.